Imaging macromolecular machines in gene regulation

My laboratory is interested in understanding the regulation of gene expression at the molecular
level. Our primary tool is cryo-electron microscopy (cryo-EM). We use cryo-EM to study the atomic
details of snapshots of our macromolecular machines of interest in action. We have revealed
exciting insights into the structure and function of macromolecular machines and assemblies
involved in (1) protein production and (2) genome editing. We will continue to apply cryo-EM as
well as other tools in our repertoire, including site-specific labeling and conformational
analysis using negative stain EM, to produce mechanistic insights into the structure and function
of macromolecular machines involved in gene regulation, broadly-defined. In the next five years,
my lab plans on elucidating the molecular architectures that set the foundation for accurate gene
expression and production of proteins, the workforce of the cell. Combined with the work on
CRISPR genome-engineering complexes, these results will have major implications for
researchers performing translational research to combat a myriad of diseases.

Public health relevance
Many diseases are linked to the abnormal function of proteins or the macromolecular complexes or machines into which they assemble. My laboratory uses structural biology to interrogate both these machines and machines that are capable of editing genes associated with diseases. By analyzing these structures, we will learn the fundamentals of how they work and how to alleviate their dysfunction that leads to disease states.